Predoctoral Training Program in Molecular and Cellular Biology (Supplement: Mentoring in the Research Environment)

ABSTRACT. The goal of the T32-Funded Molecular Biology (MOLB) Program at the University of Colorado Anschutz Medical Campus is to train outstanding research scientists and academicians who will become future leaders in their chosen fields and disciplines. As part of this this goal, we teamed up three other NIGMS T32- funded programs at University of Colorado Anschutz Medical campus to enhance mentorship training for training faculty in all four programs (comprising a total of ~214 training faculty and 121 student trainees). Specifically, programs participating in this project are: Molecular Biology Graduate Program (MOLB, T32- GM136444), Pharmacology Graduate Program (Pharm, T32-GM007635), Cell Biology Stem Cells and Development Program (CSD, T32-GM141742; formally recommended for funding starting July 1, 2021), and the MSTP Training Program (T32-GM008497). Our proposal has three major goals: (a) to develop a junior faculty mentorship training curriculum, (b) to develop an established faculty mentorship training curriculum, and (c) to establish a mentorship evaluation assessment plan. While the current project will target training faculty in MOLB, Pharm, CSD, and MSTP programs, ultimately the goal would be to use this curriculum as a basis for creating a campus-wide mentorship training platform.

Public health relevance
The University of Colorado is home to four NIGMS T32-funded programs. The main goal of this Administrative Supplement proposal is to train new facilitators and to develop new training and evaluation approaches, thereby establishing a foundation for enhancing mentorship for all four NIGMS T32-funded programs at the University of Colorado Anschutz Medical campus.